Molecular Mechanisms of Aminoglycoside Ototoxicity

PROJECT SUMMARY
Aminoglycosides are widely used to treat serious infections, as they have good activity against many multi-
drug resistant Gram-negative organisms. However, their strong and irreversible ototoxicity significantly limits
their clinical usage. The overall goal of this research is to investigate the pathological mechanisms underlying
AG ototoxicity and provide novel therapeutic targets to prevent it. We propose to investigate the functions of
aminoglycoside-binding proteins in hair cells, the sensory receptors in the inner ear. In our preliminary studies,
we have identified several proteins essential for aminoglycoside ototoxicity. Based on our preliminary data, we
hypothesize that a novel pathological mechanism is involved in aminoglycoside ototoxicity. To test our
hypothesis, we will: i) continue to investigate the expression, localization and functions of these proteins in hair
cells; ii) continue to characterize mouse lines carrying mutations in these genes; iii) continue to investigate the
functional interactions of these proteins in aminoglycoside ototoxicity. Our preliminary data show the feasibility
of our approach. We anticipate that our studies will shed new insights into the molecular mechanisms
underlying aminoglycoside ototoxicity and provide new leads for the development of new approaches to
prevent aminoglycoside-induced hearing loss.

Public health relevance
PROJECT NARRATIVE The strong and irreversible ototoxicity significantly limits the clinical usage of aminoglycosides, a class of highly potent, broad-spectrum antibiotics capable of treating multiple life-threatening infections. For this project we will investigate the molecular mechanisms underlying aminoglycoside ototoxicity. We anticipate providing new leads for the development of novel methods to prevent aminoglycoside-induced hearing loss.